Advancing a Novel, Density-Driven, Non-Invasive Thoracic Aortic Aneurysm Strength Assessment Tool

Project Summary
Thoracic aortic aneurysms (TAA) are irreversible focal dilatations of the aorta. Unrepaired TAAs can lead to death
following dissection or rupture. TAA dissection and rupture signifies a biomechanical failure of the TAA tissue
where the pressure-induced wall stress surpasses the wall strength. Therefore, a reliable assessment of the wall
strength and stress in a given TAA could be a powerful tool for predicting TAA failure. As a TAA progresses, the
stress acting on it increases, and the wall strength decreases due to breakdown and damage to the extracellular
matrix. While non-invasive estimation of wall stress in TAA through finite element analysis and other techniques
is well-established, accurate non-invasive assessment of tissue strength for direct comparison to stress has
been elusive in the advent of biomechanics-based assessments for use in TAA care.
Studies have established the tensile strength of TAA through uniaxial extension testing, including a mathematical
model for the prediction of abdominal TAA wall strength distribution. The algorithm was built using multi-variate
linear regression on several patient- and location-specific metrics and regional uniaxial tissue strength
measurements. However, the predictive power of this algorithm is only as reliable and robust as the data used
to construct it. For example, strength assessed via uniaxial tensile testing assumes material isotropy and
homogeneity when TAA tissue is anisotropic and heterogeneous. Further, TAA's physiologic loading is multiaxial,
not applied in one direction. Additionally, if the variables used to predict the strength are too few or not robustly
measured, the algorithm's accuracy can be decreased.
This proposal aims to improve the non-invasive estimation of patient-specific TAA wall strength distribution to
enable a translatable, biomechanics-based risk assessment tool for TAA. Broadly, this proposal aims to 1)
improve the accuracy and physiologic relevance of the TAA wall strength measurements used in a strength-
predicting algorithm and 2) increase the number and robustness of patient- and location-specific variables for
more accurate prediction of that strength. Goal 1 will be achieved by employing Bubble Inflation Testing (BIT),
which provides more physiologically realistic loading conditions for TAA tissue than uniaxial loading and would
provide more accurate tissue strength. BIT has been applied to ascending TAA tissue, revealing dissection-like
failure mechanisms, but not to descending TAA or non-aneurysmal aortic tissue. Goal 2 will be achieved by
leveraging the microstructural alterations that specify aneurysmal degeneration and weakening and considering
density-driven failure, which has been demonstrated in engineered materials.
This F31 Fellowship application aims to improve the estimation of TAA tissue strength distribution through
innovative and novel approaches. Successful execution of this work could lead to a translatable technology for
assessing rupture risk on a patient-specific basis by providing accurate estimates of TAA wall strength.

Public health relevance
Project Narrative Thoracic aortic aneurysm (TAA) is a growth and degradation of the aorta over time, resulting in areas of local weakness that can lead to dissection, rupture, and death. The current maximum diameter criterion cannot determine the risk of dissection or rupture, as TAAs of all sizes can dissect or rupture. The proposed research will investigate the use of diffusion tensor imaging, a type of magnetic resonance imaging, to determine regions of weakness in TAA, which, if successful, will allow for new, more accurate clinical tools for rupture analysis.